Administrative Core

Core A, the Administrative Core, will be responsible for the overall conduct and coordination across projects, investigators, and sites. Core A will: (1) Assure the scientific integrity of the overall project (2) Coordinate research and core service across sites and investigators, (3) Track work flow; (4) Deploy resources; (5) Manage communications, participant registry, and data bases; (5) Provide intellectual leadership; (6) Conduct outside scientific review. This will be accomplished by expertise from KKI (Cataldo and Johnson) and by the resources of MDLogix and the Information Systems Department of the Kennedy Krieger Institute. As such. Core A willl provide an Internet secure management system for multiple aspects of oversight and coordination of studies and data bases.